AFFINITY LABELING OF THE ADIPOCYTE HEXOSE CARRIER

Several affinity labels for the mammalian facilitative hexose carrier have been developed and will be used to study transport regulation in human erythrocytes as well as the mechanism of insulin action in rat adipocytes. The most important feature of these labels, distinguishing them from other techniques available, is that they bind to and label the hexose carrier but do not penetrate the plasma membrane of the cell. This not only allows them to be used in intact cells, but causes only carriers present and functional in the plasma membrane to become labeled. Several aspects of the translocation hypothesis of insulin-stimulated transport activation in adipocytes will be tested. This hypothesis is based on the finding that insulin treatment of rat adipocytes causes a translocation or recruitment of intracellular carriers to the plasma membrane, where they can function. Specific areas to be evaluated include: whether translocation is the sole mechanism by which insulin increases transport, whether the effect of insulin is to enhance carrier recycling and at what step, and whether internal carriers have the same labeling features as those in the plasma membrane. Since a recycling mechanism may well be involved in the more general process of plasma membrane protein turnover, experiments will also be aimed at correlating carrier movements with endocytosis and exocytosis of plasma membrane. A demonstration that carrier movements are related to cellular membrane turnover would be an important advance in the area of membrane biology in general. The carrier labels will also be used to test the hypothesis that phosphorylation may regulate either carrier function in situ or translocation, or both, and that it may be involved in the coupling process between insulin binding and transport stimulation. These investigations will help to elucidate the molecular mechanism by which insulin stimulates hexose transport and may also be feasible to apply to the study of the transport defects in obesity and diabetes mellitus.